Mechanisms for Regenerative Healing in Intervertebral Discs

Summary
Intervertebral disc (IVD) degeneration contributes to ~40% of back pain cases. Structural IVD defects
distinguish degeneration from aging and play a role pain and disability. There is a critical unmet need for
improved annulus fibrosus (AF) repair strategies since discectomy, the gold standard treatment for removing
herniated nucleus pulposus (NP) tissue from AF defects, leaves AF defects unrepaired and complications
include reherniation and recurrent degeneration-related pain. While clinical trials of IVD cell therapy show
promise to reduce discogenic pain and disability they do not involve optimized delivery strategies, and are not
informed by natural IVD healing processes since remarkably little is known about the diversity of AF cell
populations and their roles in healing. We believe an IVD regenerative healing model is required to identify
successful AF healing strategies and to identify cellular and micromechanical factors critical in successful
healing to serve as a roadmap for regenerative medicine treatments. We've developed a successful
regenerative AF healing model in mice and show neonatal IVDs with severe AF puncture heal with complete
restoration of IVD height and biomechanical properties while adults heal fibrotic deposition and loss of IVD
height and biomechanical function. The premise of this project is that neonates regeneratively heal while
skeletally mature mice do not due to increased extracellular matrix (ECM) stiffness and altered ligand
presentation resulting in terminal differentiation of AF progenitors. Aim 1 determines effects of growth,
maturation, and matrix stiffness on IVD healing and determines when the regenerative window closes. We
apply mouse models to determines the postnatal age that the AF regenerative healing window closes, if
complete AF structural regeneration is possible, and if altering ECM stiffness can extend the regenerative
healing window and prolong the age when AF cells are in mitosis. Aim 2 identifies distinct AF progenitor
populations, their loss with maturation, and roles of these progenitors in healing. We use single cell and spatial
sequencing in mouse IVDs to identify distinct AF cell populations and their localization in mice of regenerative
healing, post-regenerative healing, and regenerative restoration groups. Aim 3 engineers a soft-synthetic
substrate that promotes immature AF cell phenotypes. We identify design criteria in mouse and human ECM
and cells and control substrate stiffness, ligand type, and density using functionalized poly(ethylene glycol)
substrates. Outcomes of this project include determining when the IVD regenerative repair window closes and
if full regeneration is possible; identifying disperse AF progenitor populations and their roles in regenerative
healing; and determining critical design factors that promote immature AF progenitor phenotypes and inform
cell delivery strategies.

Public health relevance
NARRATIVE Intervertebral disc (IVD) degeneration is a major contributor to back pain and disability with a lack of effective treatment strategies, and the poor IVD healing capacity requires new ways of thinking. This project uses a novel IVD regenerative healing model and innovative genetic and microscopy tools to identify cells and extracellular matrix microenvironment factors critical for enabling IVD healing and regeneration. Next, design criteria for cell delivery are identified and validated on human cells and tissues.